Core A: Administrative Core

Project Summary/Abstract Core A The Administrative Core, Core A, will provide administrative, programmatic and fiscal management for the projects and cores of the Program Project. The goals are to organize staff and administer the projects and cores in conjunction with project leaders, core directors and institutional staff; organize and conduct monthly meetings of Program Project participants as well as annual meetings of Program Project participants. In addition, the aims will be to prepare the necessary documents related to Program Project activities, including reports of the Program Project investigator meetings, progress reports for official agencies and facilitate interaction between individual projects and between projects and cores. The Core Director will monitor the progress of the individual projects on a regular basis to maintain appropriate fiscal oversight of the projects and cores. The Core Directors will oversee the preparation of the necessary fiscal reports of official agencies and assure compliance with appropriate regulations regarding experimentation with human subjects including gender and minor participation and vertebrate animals.

Public health relevance
Project Narrative Core A The Administrative Core is necessary to organize and coordinate the administrative, programmatic and fiscal components of the projects and cores of the Program Project.